Fibromyalgia TENS in Physical Therapy Study (TIPS): an embedded pragmatic clinical trial: Administrative Supplement

Project Summary/Abstract
This is an administrative supplement to the parent grant Fibromyalgia Transcutaneous Electrical
Nerve Stimulation in Physical Therapy Study (FM-TIPS, UG3 AR0763387) to support the
predoctoral training of Dr. Andrew Post. Andrew has developed training goals that are nested
within the scientific aims of FM-TIPS that will assist him in developing his understanding of
impactful clinical trial methodology. His previous clinical experience and formal research training
will allow Andrew to serve in multiple roles that will assist in developing the necessary skills to
conceptualize and conduct pragmatic clinical pain research including recruitment of healthcare
and clinic site, training of clinicians on study procedures, data collection, management of large
datasets, data analysis, and dissemination through manuscripts and presentations at
professional conferences to a multidisciplinary audience. Andrew's contribution to FM-TIPS will
assist in facilitating the completion of the parent grant and will provide him with a
comprehensive training experience to achieve his training aims and advance his development
towards a clinician-scientist who is trained in clinical trial design at the highest level.

Public health relevance
Projective Narrative Despite clinical recommendations, non-pharmacological treatments are underutilized for chronic pain. This real-world clinical trial tests if TENS added to physical therapy practice reduces movement-pain and fatigue, and improves adherence to physical therapy in individuals with fibromyalgia. The administrative supplement will leverage experiences within FM-TIPS towards Andrew's training towards becoming an independent clinician-scientist.